Super-Resolution Microscopy of Neuronal Synapses with Advanced Imaging Tools

Significance: The ability to measure the molecular mechanisms of neuronal communication at the nanometer
spatial scale will have enormous impact on basic bioscience and likely to future clinical neuroscience. In
particular, AMPA- and NMDA-type glutamate receptors (known as iGluRs) are dynamically involved in neuron-
to-neuron communication across the thin (≈30 nm) synapse; when dysregulated, neurodegenerative diseases
result, such as Alzheimer’s and Parkinson’s diseases. We—and others—have tracked these events with
nanometric resolution using super-resolution fluorescence microscopy (SRFM). Using small probes—quantum
dots (≈12 nm diameter) and other photostable fluorophores, developed in our lab in the preceding grant—we
came up with some surprises. We find that a large fraction of the AMPARs reside in the synapse where their
mobility is restricted; during long-term-potentiation (LTP, a molecular underpinning of memory formation), we’ve
quantified their numbers and find during their maintenance phase that their lateral diffusion is rare; NMDARs
have extra-synaptic nanodomains which may keep their numbers from rising during LTP. But are these, and
other results, correct? To validate these preliminary results, we will measure the placement and diffusion of the
iGluRs, primarily AMPARs, using three different SRFM techniques, each one having its own advantages and
disadvantages. We will also determine the 3D-orientation of the synapse, the effect of probe size and type, the
details of LTP activation, and quantitatively determine the number of iGluRs at each synapse. The results
between the three techniques will be compared.
Innovation: Each SRFM technique has new aspects, particularly with respect to neuroscience. First, we will
improve the PALM/STORM technique (one type of SRFM) to test the distribution and dynamics of iGluRs more
accurately. We will use new probes—nanobodies and scFv’s—against post-synaptic proteins and iGluRs, and
test new sQDs and new cross-linking reagents against iGluRs. We will also determine the orientation and position
of the synaptic zone by labeling neuroligin and various presynaptic proteins, such as Bassoon and RIM1/2, first
under basal conditions and then with chemical LTP (cLTP). Second, we will use and develop PAINT, another
form of SRFM, which has recently been shown to have a 100× increase in speed with excellent spatial
resolution—≈5 nanometers in 0.2 sec. We will show that quantitative-PAINT can be applied to fixed neurons
and can be used to measure cLTP on an individual synapse. And for the first time, we will apply PAINT to a living
neuron under physiological conditions to measure AMPAR dynamics. With PAINT, we will be able to test how
many iGluRs there are per synapse, whether they are synaptic or extra-synaptic, and how the number of iGluRs
change with cLTP. Third, we will utilize a fluorogenic activating protein (FAP) with iGluRs and show that the
number of receptors can be measured in living neurons with nanometric resolution, no background, and
potentially fast response to cLTP. This method will therefore provide another test of iGluR structure & dynamics.

Public health relevance
Project Narrative: AMPA- and NMDA-type glutamate receptors are neurotransmitter receptors that regulate learning, memory and numerous neurodevelopmental and neurodegenerative diseases. We will develop new microscopy tools, probes, and methods to visualize their trafficking into and out of synapses at the nanometer level to help understand these processes.